Therapeutic Mechanisms of Farnesol in Modulating Gut Dysbiosis and Neuroinflammation in Multiple Sclerosis

ABSTRACT
Multiple sclerosis (MS) is a prevalent autoimmune disease affecting nearly one million individuals in the
United States. MS is characterized by neuroinflammatory demyelination within the central nervous system
(CNS), facilitated by immune cell infiltration through a disrupted blood-brain barrier, and is associated with
gut dysbiosis. Our previous studies have shown that farnesol (FOL), a metabolite of the mevalonate
pathway, delays onset, reduces severity in the experimental autoimmune encephalomyelitis (EAE) model of
MS, and reduces neuroinflammatory pathways triggered during disease. This project investigates the cellular
mechanisms underlying FOL’s therapeutic effects in EAE. FOL, found in mammalian tissues and produced
by bacteria and yeast, possesses protective benefits against cardiac and brain ischemia, neuroinflammation,
neurodegeneration, oxidative stress, and disrupted epithelial barriers. We hypothesize that FOL’s
protection in EAE is due to its beneficial impact on gut microbiota dysbiosis, intestinal barrier
permeability, and intestinal and systemic inflammation. Notably, FOL functions as a neuronal and
microvascular voltage-gated Ca2+ channel (VGCC) blocker, which might underpin its broad biological
properties. We will evaluate FOL’s impact on gut dysbiosis, intestinal barrier disruption, and inflammation at
different stages of disease progression. The specific aims are Aim #1) To determine if FOL prevents the
onset and progression of EAE-induced dysbiosis; Aim #2) To determine if FOL prevents the onset and
progression of EAE-induced intestinal barrier disruption; Aim #3) To determine if FOL effects on intestinal
barrier disruption and dysbiosis predict improved neuroinflammatory and autoimmunity markers and clinical
severity throughout the disease.
Successful outcomes will elucidate the microbiota's role in MS immunopathogenesis and offer mechanistic
insights crucial for translating preclinical knowledge into clinical applications, potentially leading to novel
farnesol-based MS therapeutics. Moreover, the project aligns with the goals of R15 proposals, which include
supporting meritorious research, involving students in research activities, and strengthening the research
environment of our institution. The project that we propose will expose our students to relevant biomedical
research and support biomedical interdisciplinary research initiatives at Boise State University.

Public health relevance
PROJECT NARRATIVE Multiple sclerosis (MS) is an autoimmune disease characterized by neuroinflammatory demyelination within the central nervous system (CNS) and is associated with gut dysbiosis. Farnesol (FOL), a metabolite of the mevalonate pathway, has been shown to delay onset and reduce severity in the experimental autoimmune encephalomyelitis (EAE) model of MS by reducing neuroinflammatory pathways and infiltration of immune cells into the CNS. This project will investigate the cellular mechanisms underlying FOL's therapeutic effects in EAE, focusing on its impact on gut microbiota dysbiosis, intestinal barrier permeability, and inflammation, potentially leading to novel FOL-based MS therapeutics.